Alzheimer's Clinical Trials Consortium (ACTC)

SUMMARY. This is a multi-PI application renewing the U24 Cooperative Agreement to sustain and expand the
NIA’s state-of-the-art Alzheimer Clinical Trial Consortium (ACTC) responsible for conducting academic clinical
trials across the continuum of Alzheimer’s disease (AD). This ACTC will continue to leverage the depth and
breadth of AD clinical research teams at USC, Harvard, and the Mayo Clinic, as well as the considerable
experience of investigators at 35 expert AD trial sites. We aim to sustain the optimized infrastructure that
efficiently develops and conducts high quality NIH supported clinical trials in AD and related dementias, while
addressing the need for Justice, Equity, Diversity, and Inclusion (JEDI) by incorporating JEDI principles across
all consortium infrastructure, activities, and studies. Building on our first five years of experience, we will utilize
streamlined contracting processes, a centralized IRB with a specific focus on neurodegenerative diseases, and
incorporate state-of-the-art informatics and statistical analyses. We will effectively manage performance of
clinical trial sites, while identifying, mentoring and supporting new trial sites to improve access to clinical trials.
We will foster continued innovation in AD trial design, providing expertise on novel cognitive, imaging, and
biomarker outcomes to support future ACTC trial applications. We will evaluate promising exploratory
measures imbedded in our current trials, such as Tau PET imaging and computerized cognitive testing, and
work to incorporate these measures into a robust platform for future Proof of Concept (POC) trials to rapidly
assess signals of efficacy. The ACTC Coordinating Center will leverage the highly experienced teams in
Clinical Operations, Data Systems and Management, and Biostatistics at USC. The MRI Unit, led by Mayo,
and PET Unit, led by Harvard and UC Berkeley, will capitalize on unparalleled experience with multi-site
protocols through ADNI, the A4 Study, and multiple ongoing clinical trials. The Clinical Outcome Instrument
and Biomarkers Units will leverage world-class expertise from Mayo, Harvard, and USC to incorporate both
standard and novel outcome measures in future trial designs. The new IDEA-CT Unit will provide training and
leadership opportunities to young clinical investigators to facilitate continued innovation in trial design, and
catalyze the next generation of AD clinical trials.
The experts comprising this infrastructure provide the highest levels of expertise to design and conduct trials
across the full continuum of AD, from primary prevention initiatives to combination trials for advanced
symptomatic stages. We will build on our successes with public/private partnerships and continue to
strengthen our strategic alliances to conduct large scale trials, while also supporting novel approaches to
smaller investigator-initiated POC studies that will better inform Phase 3 decision-making. A program
facilitating the longitudinal follow up of clinical trial participants with site assistance for brain donation,
centralizing tissue banking and sharing is another key aim of the renewal.

Public health relevance
Narrative Alzheimer’s disease (AD) remains one of greatest unmet medical needs in our country with estimates of over 5 million Americans suffering from the disease in 2016 with no new symptomatic therapies having been approved over the past 12 years, and currently no approved disease-modifying agents. The timeframe, complexity, and expense of the recruitment process and site activation for AD trials are extremely challenging, and indeed trial enrollment and site network development represent a bottleneck for drug development for the AD field; there is a growing consensus that we must fundamentally overhaul the current clinical trial recruitment and assessment structure. This proposal aims aim to create an optimized infrastructure to optimally design, efficiently launch, rapidly recruit with improved diversity, and successfully complete NIH supported clinical trials in AD and related dementias.